Administrative Core

Administrative Core: Summary
The overall goal of the Administrative Core (Core A) of this Center of Biomedical Research Excellence (COBRE)
application is to provide the leadership, services, coordination and tools necessary for the success of Research
Project Leaders (RPLs), Core Directors, Pilot Project Investigators (PPIs), the External Advisory Council (EAC),
Internal Mentoring Council (IMC) members, and collaborators. We seek to accomplish our overall goal via four
specific aims to provide: 1) Administrative leadership, services, and tools to support career development and
expansion of the community of researchers in integrated biomedical and rural health research, 2) administrative
infrastructure for the recruitment of additional faculty, 3) administrative support, services and oversight to the
Gene Editing and Mouse Models Assessment (GEMMA) Research Core, and 4) leadership and support for
evaluation and other services, as needed, to ensure successful day-to-day functioning. The Administrative Core
is significant in that it will drive development and attainment of the overall COBRE timeline and milestones for
success, support development and implementation of Career Guidance Plans, oversee the progress of the
COBRE’s four initial research projects, identify and support replacement research projects, direct the Pilot
Project Program, provide continual evaluation of projects, mentors, core leaders and administration, and develop
and implement the COBRE’s Sustainability Plan through which we can effectively transition from COBRE phase
I to COBRE II and III phases with a diversified, sustainable and applicable post-COBRE funding model. The
Administrative Core is innovative in providing continual opportunities for growth through on-the-job experience
and educational enhancement, in fostering a close working relationship between scientists, administration and
the community, in promoting the intrinsic sense of individual and collective ownership of problems and solutions,
and in innovative mentoring and partnership with the first physician medical education organization in Montana
and the largest comprehensive healthcare system in central Montana. Additional innovation derives from the
location of the CoBRE within the McLaughlin Research Institute which is the only independent nonprofit
biomedical research institute nationally that is led by a female President with a majority of female faculty. To
ensure success of the component parts and the COBRE overall, we engage in ongoing comprehensive
evaluation. In short, the Administrative Core is responsible for directing the launch, day-to-day activities, and
sustained success of the Center for Integrated Biomedical and Rural Health Research in order to expand and
enhance biomedical research across Montana and our region.